Advancing Perinatal Genomic Discoveries through Patient Engagement and Data Sharing

Project Summary/Abstract
Fetal anomalies are observed in ~2-4% of pregnancies resulting in referral for genetic counseling
and consideration of genetic testing. Although diagnostic yields for fetal anomalies have
improved, substantial barriers to identifying genomic diagnoses exist and uncertainty remains
regarding which results are appropriate to disclose prenatally. Genomic and health data sharing
has resulted in rapid improvements in our understanding of postnatal gene-disease relationships
and variant pathogenicity; similar efforts are needed to advance our understanding of prenatal
genetic diagnosis. Here, we bring together leaders from ClinGen’s GenomeConnect and the
Repository of the International Fetal Genomics Consortium (RIFGC), an expanding effort that
aggregates and standardizes genomic and prenatal phenotype data from laboratories, clinicians,
and researchers. Together, we will provide tools for patients to longitudinally engage with their
genomic data through education and bidirectional data sharing including the opportunity to receive
result updates through the work of ClinGen expert panels examining gene-disease validity and
variant pathogenicity. Our overarching goal is to enable the translation of genomic data into
precision medicine for patients undergoing diagnostic fetal sequencing (ES/GS) and to foster
ongoing engagement. This goal addresses the NHGRI’s Notice of Special Interest in
Development and Implementation of Clinical Informatics Tools to Enhance Patients’ Use of
Genomic Information (NOT-HG-22-011). We will achieve our goals through the following aims:
Aim 1: Engage participants who have had fetal sequencing to develop a patient and health
record-driven registry focused on the longitudinal collection and sharing of genomic and
phenotype data. Aim 2: Utilize participant-provided data to define gene-disease relationships,
variant classification, and natural history of disorders identified via fetal sequencing, enabling
participants to receive updated health information longitudinally. Aim 3: Evaluate parental
experiences and preferences for fetal sequencing reanalysis practices and result return to inform
study-related procedures and broader practices.

Public health relevance
Project Narrative ClinGen’s GenomeConnect, the Repository of the International Fetal Genomics Consortium, and patient participants will work together to understand the relationships between genetic variants and perinatal health by coupling longitudinal phenotype information with fetal sequencing data.